Machine Learning to Modulate Influenza Immunity

PROJECT SUMMARY/ABSTRACT
In this proposal, we will leverage "Machine Learning to Modulate Influenza Immunity" by developing and
implementing computational tools tailored towards the design of broadly protective vaccines against influenza
viruses. Machine Learning (ML)-based algorithms pioneered by us and others have revolutionized protein
structure prediction (AlphaMask, AxIEM, AlphaFold, or ESM) and design (ProteinMPNN, Rosetta) and have
improved accuracy and speed of protein engineering. Here, we will integrate Artificial Intelligence/Machine
Learning (AI/ML) and traditional computational biology to create a novel class of immunogen candidates that
overcome the inefficacy of current influenza vaccines which fail to elicit broad and long-lasting protection.
We will explore three immunogen design strategies: 1.) germline-targeting on the lateral patch of hemagglutinin
(HA), one of the most conserved epitopes in the highly immunogenic HA head domain; 2.) HA
heterotrimerization to create immunogens exposing various HA types and/or subtypes; and 3.)
epitope-focusing to shift the immune response from highly variable regions to more conserved epitopes.
Each aim will develop a computational pipeline with new algorithms for their respective immunogen design
objectives that will be iteratively refined by experimental feedback, thereby successively improving the
performance of the computational tools. In vitro experiments will provide high-throughput feedback from
mammalian surface display, including deep mutational scanning of germline-targeting mutations and deep
glycosylation scanning to evaluate the potential for immune evasion through hyper-glycosylation of HA. These
large datasets will be integrated in AI/ML tools to extend predictions to other strains and further guide future
vaccine design. To validate the effect of novel immunogen candidates, we will employ human Ig loci transgenic
mice capable of producing fully humanized B-cell receptors. To simulate the effects of original antigenic sin, a
mechanism in which primary contact with a novel immunogen has a lasting impact on subsequent antibody
responses, we will analyze immunogenicity in animals pre-immunized with wildtype HA, thereby obtaining
insights into the interaction of computationally designed immunogens with human-like antibody responses. The
in vivo experiments will be complemented by ex vivo sorting of human naïve and memory B cells with
computationally designed immunogens. All experiments will be supported by structural characterization
through computations, X-ray crystallography, electron microscopy, and mass spectrometry to identify
determinant mechanisms of protections. The efficacy of promising immunogens will be tested in lethal
challenge experiments.
We ensure the AI/ML-based computational tools developed in this project are readily available free-of-charge
and transferable to other immunogen design challenges. The deepened understanding of the interaction of the
immune system with rationally designed immunogens will support the future development of vaccines.

Public health relevance
NARRATIVE Artificial Intelligence (AI) and other Machine Learning (ML)-based methods such as AlphaMask, AlphaFold, ProteinMPNN and ESM are revolutionizing the field of structural biology and are now considered the state-of-the-art for protein structure prediction and design. By merging the expertise in computational biology (Meiler), vaccinology (Schiffner), and immunity (Crowe), this proposal will develop and employ AI/ML technologies to design broad and potent vaccines against influenza viruses. In silico designed immunogens will be evaluated in vitro and in vivo where iterative experimental feedback is used to improve vaccine candidates as well as performance of the computational tools.